The Role of Coxiella Effector Proteins in Infection and Disease

Coxiella burnetii is an intracellular pathogen that causes the human disease Q-fever. This
project is focused on the novel mechanisms Coxiella has evolved to manipulate the host
cell. The Coxiella Dot/Icm type IVb secretion system is essential for intracellular
replication. The goal of this project is to understand how effector proteins delivered into
host cells by the Dot/Icm system enable Coxiella to replicate in a hydrolytic lysosomal
organelle and evade host detection. We have developed genetic tools to identify the
important Coxiella proteins that are required for host manipulation. This project will
leverage these genetic tools in combination with molecular and biochemical approaches
to investigate how these effector proteins interfere with host pathogen sensors, promote
biogenesis of the unique Coxiella-containing vacuole (CCV), and facilitate infection in
animals. Knowledge gained from these studies will lead to a greater understanding of
pathogen adaptations that enable Coxiella to infect mammalian hosts and the immune
pathways that are important for controlling intracellular bacterial pathogens. Specific goals
include functional analysis of the proteins EmcA and EmcB that are involved in
suppression of host immune responses, using newly developed genetic tools to define
epistatic interactions between effectors required for CCV biogenesis, and to use
bioluminescence imaging to measure virulence defects displayed by Coxiella effector
mutants.

Public health relevance
Project Narrative: Intracellular pathogens represent a serious threat to human health, and to devise strategies to combat infections by these microbes a more detailed understanding of how they modulate host cell function is needed. This project is focused on identifying molecular mechanisms that allow the intracellular pathogen Coxiella burnetii to manipulate the function of host proteins, which include innate immune sensors that activate pathways of host defense against intracellular pathogens.